Project 3: Identifying transcriptional driver genes and targeting transcription in TSC

Project 3: Abstract
In this project, we will examine the transcription factors and expression pathways that drive tumor development
in tuberous sclerosis complex (TSC). We have published already that transcription is a key dependence for
TSC tumors, and that MITF is a driver transcription factor for angiomyolipoma (AMLK) development. In addition,
we have recently generated a new model of TSC renal AML by inducing renal differentiation in TSC2-/- human
induced pleuripotent stem cells (hIPSCs) to generate renal organoids. A major cell subset of TSC2-/- renal
organoids have an AML expression phenotype in contrast to control renal-differentiated hIPSCs. In separate
studies, we have used single cell RNA sequencing (scRNA-Seq) to characterize the composition of AML at
high resolution, and have confirmed the importance of MITF-driven transcription in AML cells. In the current
proposal, we will examine the JUN-AXL pathway in TSC tumor development, which leads to a novel kinase
inhibitor sensitivity. Using a Drosophila model, we will dissect in further detail how mTORC1 regulates Mitf
activity, and then translate key findings to mammalian cells. Last, we will use the TSC2-/- hiPSC renal
organoid model to identify the transcriptional circuitry required for AML development, using scRNA-Seq,
scATAC-Seq, and scChIP-Seq for H3K27ac and MITF. We will also determine the entire panel of transcription
factors required for AML cell development using Perturb-Seq applied to the TSC2-/- hiPSC renal organoid
model. Expected health-related outcomes include identification of multiple potential therapeutic approaches
for both TSC patients and cancers with TSC2/TSC1 mutations.

Public health relevance
Project 3: Narrative In this project, we will examine the JUN-AXL pathway in TSC2/TSC1 deficient tumors, clarify how MITF/TFE transcription factors are regulated in TSC null cells and tumors, and study how renal organoids derived from TSC2 null induced pleuripotent stem cells (iPSC) are dependent on transcription factors. This research has relevance for all of the tumors that occur in TSC, including renal angiomyolipomas and lymphangioleiomyomatosis. In addition, this research has potential value for any cancer with TSC gene loss, which is about 2% of all adult cancers.